Cardiac Neuromodulation: Mechanisms and Therapeutics

PROJECT SUMMARY/ABSTRACT - Overall
Our Program Project Grant (PPG) focuses on the complex interplay between the chronically infarcted heart
and sympathetic nervous system (SNS), with the goal of defining precise mechanisms of ventricular
arrhythmias and sudden cardiac death. The overarching objective of the PPG is to test ‘The Spatiotemporal
Heterogeneity of Neurotransmitter Release Hypothesis’ that postulates scars alter the ultrastructure of nerves
and result in non-uniform neurotransmitter release in the myocardium which is a crucial and proximate cause
of lethal arrhythmias. We propose to 1) understand the maladaptive interactions between the chronically
injured heart and the SNS, and 2) using this framework to investigate the mechanisms by which chronic vagal
nerve stimulation (VNS) as a prototypical neuromodulation therapy exerts its beneficial effects and gain
broader insights. Our PPG team has made seminal discoveries in cardiac neural control, cardiomyocyte
electrophysiologic function, control of ventricular tachycardia circuits at the myocardial level, and the complex
multicellular paradigms that underlie sympathetic neuronal dysfunction within stellate ganglia, the major source
of enhanced postganglionic sympathetic drive to the injured heart. These discoveries are relevant to the
electrophysiologic instabilities that underlie susceptibility to lethal ventricular arrhythmias and are a result of
the multifaceted collaborations between our PPG project & core leaders, and the broader study team. In
Project 1, Dr. Shivkumar and his colleagues will utilize novel 3D cardiac electrical mapping approaches
combined with real time in vivo neurotransmitter/neuropeptide detection in normal and chronically infarcted
beating hearts to define the mechanisms of physiologic and pathophysiologic nerve-myocyte interactions. In
Project 2, Dr. Harvey and colleagues will study, at the single myocyte level, how various neurotransmitters
(alone and in combinations seen in the normal and diseased myocardial milieu) impact cardiomyocytes from
normal hearts and from the scar-border zone. In Project 3, Dr. Ajijola and his colleagues will investigate the
source of excessive and dysfunctional sympathetic neurotransmission to the heart, specifically inflammation in
the stellate ganglia. Project 3 will investigate how maladaptive interactions between neurons and other cell
types such as glia and immune cells lead to dysfunctional control of the chronically injured heart. These three
component projects will be supported by two scientific cores, led by Drs. Ardell and Ajijola and an
administrative core led by Dr. Shivkumar. The scientific cores will provide a stream of normal and diseased
human hearts and stellate ganglia for studies in Projects 1-3, as well as high throughput tissue clearing
techniques and high-resolution imaging (Core A). The cores also aim to reproducibly generate experimental
porcine models and oversee technologies for in vivo neuropeptide/neurotransmitter release (Core B). Our PPG
team is confident in its success as we are building on pre-existing intellectual and deep collaborative
relationships among the teams and are enthusiastic about the novel hypotheses being tested utilizing
innovative tools and approaches.

Public health relevance
RELEVANCE TO PUBLIC HEALTH - Overall Our Program Project Grant (PPG) is devoted to the study of chronic myocardial infarction and sudden cardiac death, two of our nation’s most pressing public health problems. Our PPG will use new tools to examine basic mechanisms by which myocardial scars, created after infarction, interact with altered nerves around them to increase the susceptibility to ventricular arrhythmias and sudden cardiac death.